PURPOSE: THE SCOPE OF THIS TASK ORDER IS FOR THE ADMINISTRATION OF THE BASIC CONTRACT. THIS DOES NOT INCLUDE THE ADMINISTRATIVE ACTIVITIES THAT WILL B

The scope of this task is for services SRI will provide for general support for the administration of the basic contract.